Clinical and Population Sciences

Clinical investigation of HIV-induced disease requires the ability to study at-risk and HIV-infected human subjects. These clinical studies can span a broad spectrum including

Public health relevance
Scientific advances towards the prevention or cure of HIV infection requires direct research of human subjects infected with HIV or at risk for infection. However, research with human subjects is costly, time-consuming and subject to ethical constraints. To overcome these barriers, the Clinical and Population Sciences Core provides access to three different HIV-infected cohorts and advises interested investigators on the design and implementation of technically and ethically sound clinical...